Project 1

ABSTRACT
In order to effectively control HIV after ART is stopped, HIV-specific T cell responses to
therapeutic vaccination must not only be increased in magnitude, but they also must be long-
lived, have the capacity to home to sites of reservoir persistence, have the T cell memory-like
capacity to robustly proliferate and execute effector functions in response to antigen (i.e., they
need to overcome the residual T cell exhaustion that persists in pre-existing HIV-specific T cells
despite viral load suppression with ART), and be refocused to have dominant responses that
target vulnerable epitopes. Due to the limitations of standard T cell assays, and despite
emerging data from clinical trials showing at least partial control of HIV post-vaccination, little is
known about the mechanisms by which HIV therapeutic vaccine regimens transform ineffective
pre-existing HIV-specific T cell immunity into an effective antiviral response. In this Project, we
will leverage our experience performing integrated multi-modal systems immunology analysis
with paired single cell transcriptome and TCR sequencing (scRNA/TCRseq) data and high-
dimensional flow cytometry data. We will perform clonal-level analysis on HIV/SIV therapeutic
vaccine-elicited CD8+ T cells from highly unique and clinically relevant human and macaque
HIV/SIV cohorts in which therapeutic vaccines have exerted a measurable effect on altering
viral load kinetics after treatment interruption to ask: to what extent are current top-candidate
therapeutic vaccine regimens capable of recruiting new and/or pre-existing T cell clones with
optimal memory-like properties (function and differentiation state; Aims 1 and 2), and to what
extent do memory-like features (or other features) of the vaccine-elicited T cell response
correlate with post-treatment control of HIV (Aim 3)? These studies will allow us to characterize
in unprecedented depth the impact of different therapeutic vaccine regimens on critical – and
previously unmeasurable – facets of the quality of the virus-specific T cell response. Our results
will lay the groundwork for us to develop reliable measurements of virus-specific T cell clonal
structure and differentiation state that will inform iterative studies in humans and macaques.

Public health relevance
HIV therapeutic vaccines seek to elicit new T cell responses that are long-lived and have the capacity to kill HIV-infected cells in the body. However, little is known about the quality of the T cell responses elicited by leading therapeutic vaccine candidates. In this Project, we will deeply characterize HIV-specific CD8+ T cells before and after vaccination in unique cohorts of people and macaques in order to better understand what kinds of T cells are elicited by the vaccines and how they can be harnessed to control HIV after antiretroviral therapy is stopped.